Mechanisms regulating neural stem cell maintenance in the dentate gyrus

Project Summary
Dr. Bond’s primary career goal is to run her own independent academic research group broadly investigating
how principles of brain development can be used to understand and manipulate adult brain plasticity and
regeneration. To accomplish this goal, Dr. Bond must gain training in single-cell biology techniques and advance
her career development. The proposed research and career development plan has been specifically designed
to fulfill Dr. Bond’s unmet training and prepare her for the next independent stage of her career. The plan includes
research training in new technical skills, including ex-vivo time-lapse imaging, single-cell RNA-sequencing, and
bioinformatic analysis of large-scale omics datasets, as well as career development training, including grant
writing, lab management, mentoring, and scientific communication skills. The proposed research will be
conducted at the University of Pennsylvania’s Perelman School of Medicine under the direct mentorship of Dr.
Hongjun Song, a professor in the Department of Neuroscience and a world-renowned expert in neural stem cell
biology. The Perelman School of Medicine boasts exceptional resources for trainees, including expansive core
facilities, state-of-the-art laboratory space, and significant career development training and resources, which will
together serve as the ideal environment for carrying out the proposed research and career development plan.
The main objective of the proposed research is to understand the developmental process and molecular
mechanisms that promote dentate gyrus neural stem cell quiescence and maintenance beyond development. A
multipronged approach, including single-cell, candidate gene, and transcriptome-wide methods, will be used.
First, clonal lineage tracing and time-lapse imaging experiments in Aim 1 will determine the timing and cellular
behaviors that predict neural stem cell transition into quiescence during neonatal development. Then, genetic
deletion experiments in Aim 2 will investigate how β1-integrin signaling is required for proper establishment of
the quiescent neural stem cell pool during neonatal development, which could subsequently have long-term
effects on adult neurogenesis. Finally, in Aim 3, single-cell RNA-sequencing of neural stem cells across neonatal
development will reveal the molecular cascade that drives neural stem cell quiescence and maintenance during
neonatal dentate gyrus development. The proposed research is well-aligned with the National Institute of Mental
Health’s interest in basic research aimed at understanding the complex biological processes that direct
neurodevelopment. Results from the proposed project will advance our understanding of neural stem cell
maintenance and will have long-term applications for enhancing neural plasticity and neuroregeneration.

Public health relevance
Project Narrative Unlike neural stem cells in most other regions of the brain which disappear following development, dentate gyrus neural stem cells become quiescent so that they can remain in the adult brain, generating new neurons and contributing an added layer of plasticity to the hippocampal circuit throughout adulthood. The proposed research aims to understand the special developmental process that leads to the establishment of quiescent dentate gyrus neural stem cells and will give us insight into mechanisms that promote long-term neural stem cell maintenance. Future studies may translate the fundamental principles of neural stem cell maintenance derived from this research into therapeutic interventions to enhance neural plasticity and neuroregeneration in the adult brain.